Stanford MoTrPAC Bioinformatics Center

Abstract
Few interventions have been shown to be as beneficial to human health as physical exercise, yet we remain
largely ignorant of the mechanisms by which those potent effects are transduced. The Molecular Transducers
of Physical Activity Consortium examines the response to acute and chronic exercise at multiple scales and in
multiple tissues across thousands of humans and in animal models. The studies of the Consortium combine
state of the art phenotyping with molecular omics approaches. Building on our long history of analytical
innovation in high throughput biology and experience in the analysis of perhaps the largest multi-omic study
funded to date, the Stanford MoTrPAC Bioinformatics Center provides core compute, storage and analytic
expertise to the MoTrPAC investigators. In this administrative supplement, the MoTrPAC BIC proposes to
formally join the CFDE; to contribute to data organization to enhance MoTrPAC dataset FAIRness; to regular
interact with other CFDE entities; and to advance the mission of the Common Fund Data Ecosystem. We
propose to interface and collaborate with the Common Fund Data Ecosystem to improve the interaction of
MoTrPAC data with other Common Fund data resources. Aim 1 is focused on develop data standardizations
and reproducible analysis pipelines for various ‘omes in collaboration with the CF DCCs that can be
repurposed and customized by the scientific community; we will start with transcriptomic data processing
optimization in collaboration with several CFDE entities. Aim 2 proposes to harmonize the data catalog of the
MoTrPAC BIC with the CFDE data model and to record and analyze user experience and deploy tools and
training for the research community to easily use existing datasets to address novel cross-cutting biological
questions
. We expect that with the above aims and activities, we will contribute towards CFDE’s long term goal
of developing and deploying resources and tools, training materials, empowering the research community to
use CF data sets for novel scientific research, hypothesis generation, discovery, and validation, leading to new
insights into health and disease.

Public health relevance
Project Narrative The Molecular Transducers of Physical Activity Consortium (MoTrPAC) examines the biological response to exercise using state of the art tools across thousands of humans and in animal models. The Stanford MoTrPAC Bioinformatics Center provides core compute, storage and analytic expertise to the MoTrPAC investigators. The MoTrPAC Bioinformatic Center will collaborate with the Common Fund Data Ecosystem to enhance the usability and interconnectedness of MoTrPAC and other Common Fund data.